The ECHO Measurement Core: A Framework and Resource for Assessing Environmental Exposure and Child Health

Environmental exposures profoundly shape lifespan health and disease trajectories. Preconception and pre-
perinatal exposure can permanently alter the developing brain and associated regulatory systems to increase
susceptibility to a host of diseases and developmental challenges. Protective and promotive environmental
factors can promote well-being, even amidst adversity. The ECHO Consortium of Cohort Study Sites, Cores,
and Centers is dedicated to mapping the impact of early exposures on child health and development. Good
science depends on good measurement. Our proposed ECHO Measurement Core will advise, orchestrate, and
frame the coordinated, sensitive measurement of exposures, developmental processes, and health outcomes
central to achieving ECHO's objective. We propose three aims. Aim 1 is to develop and refine measures for the
ECHO Cohort Protocol (ECP), including methods to implement the measures. We will lead efforts to optimize
the measurement of exposures and outcomes, mindful of best measurement practices as well as respondent
and staff burden. We will lead the timely development of a preconception section for the Protocol by drawing on
diverse expertise across the ECHO Network to ensure feasible, robust, and culturally sensitive assessment of
critical data elements in the preconception period that have direct import for the primary ECHO child health
outcomes (pre-, peri-, post-natal, airways, obesity, neurodevelopment, and positive health). We will leverage
novel psychometric and technological methods such as computer adaptive tests, wearable sensors, and other
innovations in remote assessment, to reduce barriers to study participation and enhance participant retention.
Aim 2 is to assist the ECHO Consortium in implementing and evaluating the ECP. We will further collaborate
with everyone in the Consortium to finalize the protocol and establish a standard implementation strategy that
can be implemented across the diverse Cohort Study Sites, including determining optimal study visit structure
and choreography, developing Manual(s) of Operating Procedures (MOPs), and creating, supporting, and, when
appropriate, leading training. Aim 3 is to lead strategic decision-making and operational strategies to incorporate
new and revised measures to advance ECHO Cohort science while minimizing participant and staff burden. We
propose to optimize measurement decisions by maintaining collaborative communication, rapidly deploying data
and biospecimen collection for time-sensitive needs, identifying and evaluating important measurement
developments, creating a technology pipeline for rapid adoption of innovative approaches to data collection, and
ensuring data collection strategies are validated for diverse populations. Our measurement science expertise
within and outside of ECHO, paired with our participant-centered approach, enables us to bridge reliable and
valid assessment with practical feasibility and ultimately allows us to bring ECHO scientists together toward our
shared goal of mapping the impact of early exposures on child health and development.

Public health relevance
Environmental exposures profoundly shape lifespan health and disease trajectories. The ECHO Measurement Core will advise, orchestrate, and frame the coordinated, sensitive measurement of exposures, developmental processes, and health outcomes central to achieving ECHO's objective of mapping the impact of early exposures on child health and development. We will develop and refine measures for the ECHO Cohort Protocol (ECP), including methods to implement the measures that are culturally sensitive and valid for diverse populations, assist the ECHO Consortium in implementing and evaluating the ECP, and we will lead strategic decision-making and operational strategies to incorporate new and revised measures to advance ECHO Cohort science while minimizing participant and staff burden.